Administrative and Informatic Core

The goal of this core is several. It's primary goal is integrative in nature and to provide an infrastructure with UNMHSC that enhances the interactions within the program and optimizes the issues related to accomplishing the aims including those related to ordering of supplies, regulatory and compliance information and one that is often overlooked but is becoming more important as data becomes more complex, centralized data collection. Specifically this core will: 1) Provide the infrastructure for PIs and their staff to order supplies and animals in order to accomplish their aims 2) Coordinate scheduling and usage of the ABSL III 3) Maintain records, monitor and update compliance data related to projects and core 4) Coordinate meetings among PIs and external and internal advisory committees 5) Provide support for noncompetitive renewal reporting 6) Maintain a centralized repository of data to allow for data comparisons within projects as well as compare data among different projects.